Laryngeal and vocal tract strategies to reduce vocal fold contact pressure

ABSTRACT
Voice therapy remains the primary treatment option for phonotraumatic vocal hyperfunction, one of the
most frequently occurring conditions to affect the voice. Voice therapy aims to modify hyperfunctional vocal
behavior through vocal techniques or exercises, often with a focus on vibratory sensations in certain parts of
the airway. It is generally believed that these techniques and exercises induce adjustments in the larynx and
vocal tract that increase vocal efficiency and lower vocal fold contact pressure, an important contributing factor
to vocal fold injury. However, such understanding is largely based on theoretical and numerical simulations,
and there have been few experimental data supporting these hypotheses. Additionally, although voice therapy
likely leads to multiple simultaneous laryngeal and vocal tract adjustments, information about the specific
adjustments and their impact on vocal fold contact pressure is often vague. Currently, voice therapy outcomes
are often evaluated based on patient-reported and other secondary measures. To date, no objective measures
have been identified that would allow clinicians to reliably monitor and predict the progress of voice therapy
with greater accuracy than is currently available. The goals of the proposed research are to (1) experimentally
validate findings and hypotheses from previous numerical simulations on favorable laryngeal and vocal tract
configurations that consistently reduce vocal fold contact pressures in excised human larynx experiments; and
(2) investigate the effectiveness of voice therapy methods in reducing vocal fold contact pressures and in
eliciting the hypothesized laryngeal and vocal tract configurations to do so, and the ability of these maneuvers
to predict voice therapy outcomes.

Public health relevance
PROJECT NARRATIVE Successful completion of the proposed aims will provide a systematic, experimentally validated understanding of how laryngeal and vocal tract adjustments affect voice production and vocal fold contact pressure, and a better understanding of the scientific rationale for voice therapy in treating patients with phonotraumatic vocal hyperfunction. In the long term, the identification of potential objective predictors of voice therapy outcomes will allow clinicians to better monitor and target patient-specific vocal behavior to improve treatment outcomes in voice therapy.